Prenatal Alcohol Exposure and Fetal Alcohol Spectrum Disorder

the direct impact of alcohol (and its metabolic byproducts) on viral replication of Kaposi’s sarcoma
herpesvirus (KSHV). Our preliminary findings show alcohol and alcohol biproducts accelerate
KSHV reactivation. Greater viral reactivation is correlated with higher levels of circulating viruses,
and an increased risk to develop KSHV-associated malignancies. KSHV is one of the eight
identified oncogenic viruses. KSHV is the etiological agent of three human cancers, Kaposi’s
sarcoma (KS), primary effusion lymphoma (PEL) and Multicentric Castleman’s disease (MCD).
Like all herpesviruses, once infected KSHV establishes a lifelong infection. To investigate the
relationship between alcohol consumption in the background of persistent KSHV infection, we
seek to study the alcohol induced epigenetic modifications to the KSHV episomes and alcohol
enhanced extracellular vesicle (EV) production in increasing viral spread. Based on our data, we
hypothesize that alcohol exposure sensitizes latently infected cells to a more rapid reactivation of
lytic replication via alternations to the viral episomes epigenetic modifications. DNA chromatin
remodeling of the viral genome will promote transcription of lytic transcripts and subsequent lytic
proteins. Alcohol consumption also augments the release of cellular extracellular vesicles (EVs).
Viral-mediated EV release not only boosts paracrine delivery of key viral RNAs and proteins but
can dictate cellular products are packaged within the excretory vesicles to enhance immune
escape and drive non-specific cellular uptake. Thus, alcohol-enhanced EV delivery from latently
infected cells may further sensitize neighboring cells to future promotion of more viral infection.
We propose to study the role of alcohol enhanced EV production on the viral lifecycle and
mechanism of viral spread. We propose a unique transdisciplinary approach to obtain innovative
data defining the consequences of a modifiable risk factor, alcohol consumption, on disease
progression. Our findings can be applied in future studies to related herpesviruses, such as EBV,
which infects most of the world population, thereby increasing our understanding of the likelihood
of alcohol-induced consequences to persistent oncogenic viral infections.

Public health relevance
KSHV serves as a model virus to assess the impact of alcohol on persistent viral infections and the viral lifecycle. The goal is to understand the primary impact of ethanol exposure and identify the cellular and viral pathways that are modified in the presence of ethanol. These studies with KSHV will be relevant impact of alcohol exposure on lifelong viral infections of other closely related oncogenic herpesviruses, such as Epstein Barr Virus (EBV) and non-oncogenic herpesvirus infections (HSV-1, -2).